Professional Development Core (PDC)

PROFESSIONAL DEVELOPMENT (PD) CORE ABSTRACT/SUMMARY

Despite ongoing efforts, participation of researchers from Puerto Rico (PR) in clinical and translational (C&T) research is limited. Addressing this gap is critical for fostering a broader and stronger research environment. Continuing professional development is essential to overcoming needs identified by The Alliance in previous cycles, such as enhancing research skills, expanding mentorship networks, increasing participation, and strengthening clinical trial expertise. Additionally, providing investigators with training and resources that support career advancement is essential. The goal of the Professional Development (PD) Core is to support investigators at all career stages—from early to established—by prioritizing major health problems affecting populations within the Alliance Clinical and Translational Research Network (CTR-N). The PD Core will offer targeted training, mentorship programs, and services designed to bolster the development pipeline for C&T research investigators from institutions within The Alliance. We propose the following Specific Aims: (1) Strengthen infrastructure and enhance the skills of researchers and staff through an educational program to advance research on health and healthcare; (2) Provide comprehensive training and mentoring to support the ongoing development of a pipeline of clinical and translational investigators in Puerto Rico; and (3) Improve community health by offering targeted training to healthcare providers and community members, enabling them to conduct research focused on community health needs. These aims will address existing gaps, building capacity for a more skilled research community, and foster collaboration to address health concerns in Puerto Rico and in the U.S. Mainland, in conjunction with other Alliance Cores, partners, and external collaborators.

Public health relevance
The mission of the Professional Development (PD) Core is to strengthen the infrastructure needed to develop a research workforce capable of addressing health challenges in Puerto Rico. The Core’s targeted resources, training, and mentorship programs are essential for empowering researchers, healthcare providers, patients/participants and community members to conduct impactful research and advance public health outcomes.